EFFICACY OF PLATELETS STORED IN CPD/XT-612 BLOOD BAGS

This study looks at the response of patients to platelets obtained by and stored in different ways. This particular study looks at platelets stored in one particular anti-coagulant blood bag combination.